Studies of Occupational Cancer (Pesticides)

The Agricultural Health Study (AHS) is a major effort which is designed to evaluate the relationship between pesticides and other agricultural factors and the risk of cancer and other diseases. Enrollment in this study includes about 90,000 men and women from Iowa and North Carolina. From 1993-1997 detailed information was obtained by self-administered questionnaire and from 1998 through September 2003 computer assited telephone interview has up-dated the information collected at enrollment. Telephone interviews include questions on pesticides used and other agricultural exposures, lifestyle factors, medical and family history of disease, and diet. We are also collecting buccal cell samples as a source of genomic DNA on all members of the cohort. Analyses on cancer incidence and other chronic diseases is continuing and a number of manuscripts focusing on cancer incidence overall, prostate cancer, breast cancer, and lung cancer are now published . Analysis of NHL and leukemia is now underway. Findings from the prostate cancer anlysis suggests a number of pesticides are associated with a prostate cancer risk. The risk of prostate cancer is particularly strong among those with a family history of prostate cancer. The Agricultural Health Study has also analyzed the cancer experience of pesticide applicators who have used chlorpyrifos, alachlor, atrazine, glyphosate, malathion, metoachlor, dicamba, fonofos, phorate and a number of other pesticides of wide-spread use and toxicologic interest. Results from the reanalyses of atrazine, chlorpyrifos and glyphosate should be available in 2007. A biomarker study [The Corn Farmer Study], nested within the AHS is assessing perturbations in the immune system of a group of Iowa corn farmers and a control group not exposed to corn farming, during a calendar year, some result are expected in 2007. A nested molecular case-control study of prostate cancer will begin in 2007. A cross-sectional study of neurobehavorial effects of pesticides and MGUS and pesticides will begin in 2007 as well. In a case-control study nested with the Agricultural Health Study, retinal degeneration was significantly associated with exposure to fungicides and selected insecticides, further analyses is now being conducted on this finding. The risk of a high pesticide exposure event resulting in symptoms is more pronouned among farmers whose farms were in poor financial condition compared to those whose farms were not and among those with a higher risk acceptance than those with a lower risk acceptance. Several manuscripts with analyses of mechanical injury associated operating a farm have been prepared and submitted for publication. Several manuscripts with analysis of respiratory wheeze have been published indicating that diesel tractor use, work in poultry operations and exposure to several pesticides are risk factors for respiratory wheeze. These cross-sectional studies will be follow-up with additional longitudinal analyses in 2007. A study of Parkinson's disease nested within the Agricultural Health Study is now in the data analysis phase of the study. Several other projects to evaluate the cancer risk from pesticide exposure are underway. Analysis of data from case-control studies of non-Hodgkin's lymphoma noted an association with agricultural use of lindane, but not with DDT. However another case-control study indicated that chemotherapy for non-Hodgkins Lymphoma affects blood levels of organochlorines, which could result in misclassification of exposure and distort findings. Farmers were found to be at elevated risk for prostate cancer in a study of mortality in 24 states. Contrary to earlier investigations, however, the risk of breast cancer was not associated with serum levels of DDT among women in Mexico City. A methodologic study to compare pesticide levels in dust samples from vacuum cleaner bags with levels from a high-volume surface sampler (HVSS) found a high degree of correlation. This suggests that collection of vacuum cleaner bags, which is a simpler and less expense approach than the HVSS, provides a reliable indication of pesticide levels on dust in homes. Several feasibility studies have been conducted among migrant and seasonal farm workers to determine appropriate methods for epidemiologic investigations in this understudied group. Results from this effort appear in a special volume of the American Journal of Industrial Medicine in the near future. A review of the literature was conducted which suggested that pesticides may play a role in the development of childhood and adult cancers. Recently completed case-control studies of cancers of the brain and stomach in Nebraska will provide the opportunity to assess the role of agricultural, general environmental, and lifestyle factors in the development of these tumors. Blood and urine have been collected from 30 applicators applying the herbicide 2,4-D to relate dose to possible biologic effects, and dose-response gradient was found for 2,4D and mitotic index. In a separate study, preliminary results suggest that farm exposures are more strongly associated with NHL with a t(14,18) translocation than other types of NHL. In yet another study, preliminary results suggest that maternal occupational exposure to agricultural chemicals may increase the risk of giving birth to a child with limb defects.